ELECTRICAL ACTIVATION OF PARASPINAL MUSCLES IN THE TREATMENT OF SCOLIOSIS

The purpose of this study is to determine the efficacy of electrically activating the deep paraspinal muscles on the concave side of a scoliotic curve. This is an FDA approved study to activate the multifidus and rotator muscles in patients with adolescent idiopathic scoliosis using a percutaneous signal delivery system.